Multidisciplinary Anesthesiology and Perioperative Medicine Research Training Program

Abstract
The Department of Anesthesiology and Perioperative Medicine (DAPM) at UCLA has a long tradition of academic
productivity and excellence as reflected by our consistent ranking among top 10 Anesthesiology departments in
the country. The department has trained many leaders in the fields of Anesthesiology, Critical Care and Pain
Medicine and has a long history of excellence in both basic and clinical research. The main goal of our T32
training program is to provide training and mentoring to anesthesiology residents/fellows/junior faculty early in
their careers in basic, translational, and preclinical research in the department. Our T32 research training
program has four main research themes: 1) Perioperative Organ Protection, 2) Cardiovascular, 3) Neurosciences
and Brain Health, and 4) Biocomputing/Bioengineering and Health Informatics. The department has strong
leaders in each of these fields. We have recruited 27 exceptional faculty mentors (13 PhD scientists and 14
physician-scientists) from the Department of Anesthesiology and other departments across UCLA, including the
Departments of Medicine, Bioengineering, Physiology, Surgery, Pathology, Molecular, Cell, and Developmental
Biology, Psychiatry and Biobehavioral Sciences, Computer Science, and Human Genetics. Our faculty have
expertise in a wide range of research areas broadly related to the anesthesiology specialty. Eleven of these
faculty are from the Department of Anesthesiology. We have also recruited eight junior anesthesiologist-
scientists from our department as “Up and Coming Faculty”. All of these junior faculty are on track to becoming
independent physician-scientists and are dedicated to training the next generation anesthesiologist-scientists.
We request two trainee slots for the first year and three slots thereafter. We will focus our recruitment efforts
towards outstanding MD and MD/PhD candidates from the pool of our residents (mainly from Research Scholars
Track, which is a five-year program that includes almost two years of protected research time junior faculty, or
Research Pathway that includes up to 11 months of research during residency) as well as our fellows and junior
faculty. We will require a minimum two-year commitment from our T32 trainees but will extend the training to
three years if the additional year is beneficial to the individual upon approval from the T32 Executive Committee.
Our T32 training program is specifically designed to train the next generation of academic anesthesiologists to
become independent physician-scientists in the field of Anesthesiology and Perioperative Medicine.

Public health relevance
Project Narrative The goal of our T32 training program is to train the next generation of academic anesthesiologists to become independent physician-scientists in the field of anesthesiology and perioperative medicine. Our T32 research training program has four main research themes: 1) Perioperative Organ Protection, 2) Cardiovascular, 3) Neurosciences and Brain Health, and 4) Biocomputing/Bioengineering and Health Informatics.